Safe and Effective MRI for Pediatric Patients with a Cardiac Implantable Electronic Device

Abstract: A substantial number of infants and children with congenital heart defects (CHD), inherited arrhythmia
syndromes, and/or congenital disorders of cardiac conduction require a cardiac implantable electronic device
(CIED). The current approach to affixing a CIED lead to the heart of a young patient is to open the chest and
sew the lead directly to the epicardium (“epicardial leads”), whereas the approach in older adolescents and adults
is passing it through veins and affixing to the endocardium (“endocardial leads”). Once epicardial leads are
implanted, however, the patient is no longer eligible for routine magnetic resonance imaging (MRI) due to the
increased risk of radiofrequency (RF)-induced heating of myocardial tissue. The problem is exacerbated by the
fact that there is no straightforward method to extract leads, so children who receive such leads are excluded
from the benefits of MRI even if a subsequent FDA-approved endocardial CIED system replaces an epicardial
system when they are older. Such patients are often referred for alternative imaging modalities with ionizing
radiation, which may result in suboptimal care and a significant radiation risk for children. Our strong, preliminary
data show that CHD patients with a CIED have four-fold higher cumulative effective doses of radiation from
computed tomography and X-ray than matched pediatric CHD patients with no CIED, thereby highlighting an
urgent need to increase access to MRI for pediatric CIED patients. The 2017 HRS consensus statement is blunt
in emphasizing the need for more research: “Given the paucity of data related to the safety of MRI [with epicardial
leads], recommendations cannot be made [and] many questions remain unanswered.” Even if MRI safety issues
are resolved through engineering, the diagnostic yield of cardiac MRI remains low due to severe image artifact
caused by the Implantable Pulse Generator (IPG). Existing “wideband” pulse sequences developed for adults
are unsuitable for pediatric CIED patients due to two main reasons: (a) the proximity of IPG to the heart is closer
in pediatric patients than adults, necessitating a wider bandwidth RF pulse design; (b) pediatric patients have
smaller hearts and faster heart rates than adults, necessitating higher data acquisition acceleration. In direct
response to this unmet clinical need, this study seeks to develop innovative technologies to achieve the following
three objectives: (1) determine imaging conditions under which MRI can be performed safely in children,
regardless of CIED types and abandoned leads; (2) develop, implement, and validate physics-based epicardial
lead implantation strategies that minimize the variation and magnitude of RF heating in pediatric patients with a
CIED; (3) develop and validate age-specific, free-breathing, wideband cardiovascular MRI pulse sequences that
produce diagnostically acceptable image quality in pediatric CIED patients. If successful, our work will extend
MRI access to a growing number of pediatric patients with a CIED and deliver age-specific free-breathing
wideband pulse sequences that produce diagnostically acceptable image quality.

Public health relevance
PROJECT NARRATIVE: This study seeks to develop new technologies to perform magnetic resonance imaging (MRI) safely and effectively in children implanted with a cardiac implantable electronic device (CIED). Specifically, this study will: (a) provide recommendations on how to perform MRI safely in these patients with existing CIEDs; (b) provide recommendations on how to configure future CIED implantations, in order to make MRI even safer; (c) deliver robust cardiac MRI methods that produce image quality in these patients that doctors can interpret with high confidence. Our study has high potential impact because it will extend MRI access to a growing number of pediatric patients with a CIED and establish an effective MRI for doctors to care for these patients.